VAAST+: Tool for variant prioritization, risk assessment and disease-gene finding

DESCRIPTION (provided by applicant): The overarching goal of this proposal is to produce a single deliverable: VAAST+, which will provide innovative and improved solutions for three major bottlenecks in analyses of personal genomes data: variant prioritization, risk assessment and disease-gene finding. Better variant prioritization and risk assessment will aid diagnostic laboratories and clinicians seeking to interpret the impact of rare variants discovered in the course of routine genetic testing; whereas a better tool for disease-gene finding will empower researchers seeking to employ whole-genome and exome sequences to identify novel genes and disease-causing alleles responsible for rare and common diseases. VAAST+ will leverage the VAAST platform, which was developed with support from an NHGRI Grand Opportunity Grant entitled Tool for annotation and analyses of human whole-genome sequence variation data. Doing so will allow us to rapidly implement VAAST+ and distribute it to the research community.

Public health relevance
PUBLIC HEALTH RELEVANCE: Whole-genome and exome sequencing, as well as sequence�based clinical diagnostics are increasingly uncovering rare and novel variants that may or may not impact patient health. The overarching goal of this proposal is to produce a single deliverable: VAAST+, which will provide basic researchers, clinical diagnostics laboratories and clinical geneticists with the means to rapidly identify and characterize disease-causing variants; thus bringing sequence data one step closer to the bed-side. VAAST+ will do so by providing innovative solutions to the three principal bottlenecks in healthcare-focused genome analyses today: variant prioritization, risk assessment, and disease-gene finding.